: Can MEP conditioning improve corticospinal recruitment of motoneurons in chronic cervical SCI?

Project Summary
After spinal cord injury (SCI), the excitability and connectivity of cerebral cortex – spinal cord (corticospinal)
pathway diminish, often resulting in weak voluntary activation of muscles and impaired motor control. Yet, such
corticospinal impairments are reversible at least partially, and an intervention that improves corticospinal
excitability for the affected muscles may enhance motor function recovery. At present, no interventions that target
corticospinal pathways for treating motor dysfunction are readily available to people with SCI. Operant
conditioning of the motor evoked potential (MEP) to transcranial magnetic stimulation (TMS) to induce targeted
plasticity in the corticospinal pathway may become one of those interventions. Indeed, in lower limb, people with
SCI can increase corticospinal excitability through operant up-conditioning and can improve walking. Supported
by those findings, our core hypothesis is that MEP operant conditioning can increase the corticospinal excitability
for the targeted muscle and improve its activation and motor functions in which it participates. Regaining
arm/hand function is one of the top priorities of individuals with tetraplegia and often most challenging. Through
mass practice and conventional therapy, functions can be restored partially, but it is likely through compensation
rather than induction of relevant corticospinal plasticity. In such cases, corticospinal recruitment of motoneurons
and resulting muscle activation could remain impaired and continue to limit function recovery. Abnormal
motoneuron recruitment and motor unit firing hinder effective production of motor functions. Thus, to enhance
upper limb motor rehabilitation beyond what conventional therapy has achieved, a method to improve
corticospinal recruitment of a targeted pool of motoneurons would be needed.
Here, we hypothesize that wrist extensor MEP up-conditioning can improve forearm motor functions in people
with cervical SCI by increasing the corticospinal excitability and improving corticospinal recruitment of wrist
extensor motoneurons. Towards testing this hypothesis, this R21 project aims: (1) to demonstrate that the wrist
extensor MEP becomes larger through operant up-conditioning in people with chronic incomplete cervical SCI,
Extensor Carpi Radialis (ECR) MEP is up-conditioned in individuals with weak wrist extension due to chronic
cervical incomplete SCI; (2) to obtain preliminary data for the functional effects of MEP up-conditioning in people
with chronic incomplete cervical SCI, multiple functional tests will be performed before and after conditioning
intervention; and (3) to examine whether corticospinal recruitment of wrist extensor motoneurons changes with
MEP up-conditioning, motor unit firing is studied using high-density surface EMG (HDsEMG) before and after
conditioning intervention.
This R21 is the first step in understanding how MEP conditioning may improve upper limb functions and
corticospinal recruitment of motor units in cervical SCI. Since upper limb functions have tremendous impact on
the health, independence, and quality of life in people with tetraplegia, improving them is of critical importance.

Public health relevance
Project Narrative Developing new neurorehabilitation strategies to improve corticospinal recruitment of motoneurons is critically important for enhancing upper limb function recovery and thereby improving quality of life in people with chronic cervical SCI. Through this project, we seek to examine how motoneuron recruitment and firing behaviors change with MEP operant conditioning in forearm muscles of individuals with SCI. Successful completion of this project will provide invaluable preliminary data for guiding future MEP conditioning and motor unit studies and accelerate clinical translation of MEP operant conditioning as a novel non-invasive therapy that may complement other therapies and enhance upper limb function recovery in people with SCI.